ZALEPLON FOR THE TREATMENT OF INSOMNIA IN OLDER SUBJECTS

The purpose of this study is to determine the safety and effectiveness of an investigational new drug, Zaleplon (CL284,846), for the treatment of insomnia in older subjects.